SLEEP DEPRIVATION ON SLEEP AND SLEEP-RELATED HORMONES IN NORMALS

Sleep deprivation or prolonged wakefulness in humans is associated with increased daytime sleepiness the next day and increased slow wave activity in the recovery night. The underlying biochemical/hormaonal factors that mediate these sleep alterations are unknown. Delta sleep-unduced peptide (DSIP) has been reported to have sleep-inducing and maintaining properties and to increase slow wave sleep (delta sleep) in animals and men. Also, the secretion of growth hormone has been associated with sleep onset and slow wave sleep particularly, while cortisol is at its minimum during the first two hours of sleep. The objective of this project is to assess the relationship between slow wave sleep and the levels of these hormones.